Intra-cartilage depot delivery of electrically-charged IL-1RA for targeting osteoarthritis-associated inflammation and catabolism in multiple joint tissues

Project Summary
Despite the existence of promising osteoarthritis (OA) drugs, its treatment remains a challenge due to ineffective
drug delivery systems. Intra-articular (IA) delivery is inadequate as drugs rapidly clear out from joint space and
are unable to penetrate through the dense, negatively charged cartilage and reach their cell and matrix target
sites at optimal concentrations. As a result, no disease modifying OA drugs (DMOADs) have passed clinical
trials due to concerns of systemic toxicity and lack of cartilage targeting. For effective treatment, it is critical to
stimulate a disease modifying biological response within multiple joint tissues, including cartilage, synovium and
subchondral bone. Interleukin (IL)-1 receptor antagonist (IL-1RA) is proven to be a promising DMOAD for
modulating both synovium inflammation and cartilage catabolism in preclinical models of post-traumatic (PT)OA;
however, it has failed to show sustained clinical effect owing to lack of cartilage targeting and short joint residence
time. The high negative charge density of cartilage provides a unique opportunity to use electrostatic interactions
for enhancing uptake, depth of penetration, and retention of cationic drugs or drug carriers. We have shown that
the cationic glycoprotein Avidin, owing to its optimal size and charge, was effective for intra-cartilage delivery as
it rapidly penetrated through full thickness of cartilage in rats and rabbits following IA injection, resulting in 400-
fold higher intra-cartilage uptake compared to its neutral counterpart and was retained inside cartilage for 3-4
weeks. Based on Avidin’s structure, we have designed a Cationic Peptide Carrier (CPC) that displayed similarly
high uptake in both normal and glycosaminoglycan-depleted cartilage. This project will develop electrically
charged IL-1RA by conjugating it with Avidin and CPC to make it cartilage penetrating and binding, thus
increasing its tissue specificity and residence time. This way, cartilage can be converted from a barrier to drug
entry into a drug depot, such that the anti-catabolic effects of charged IL-1RA in both cartilage and nearby
synovium are significantly enhanced compared to unmodified IL-1RA. In Aim 1, Avidin-IL-1RA and CPC-IL-1RA
will be characterized and their key transport properties (diffusivities, equilibrium uptakes, partitioning, binding
constants) will be compared with unmodified IL-1RA in normal and arthritic cartilage. Aim 2 will evaluate the
biological efficacy of a single dose of charged IL-1RA for inhibiting cytokine induced catabolism in a cartilage-
synovium co-culture OA model, comparing Avidin/CPC-IL-1RA conjugates with single and continuous dose of
unmodified IL-1RA. Aim 3 will determine the therapeutic potential of a single IA injection of charged IL-1RA
relative to unmodified IL-1RA using a rabbit PTOA model. This work will advance the field of charge based drug
delivery in targeting multiple joint tissues for effective, holistic OA treatment by applying fundamental concepts
of bio-electrostatics and bio-transport. This charge-based platform can be used for delivering a wide range of
drugs to other tissues with similar properties, such as meniscus, intervertebral disc and fracture callus, and also
enable clinical translation of various OA drugs that have failed clinical trials due to lack of tissue targeting.

Public health relevance
Project Narrative Osteoarthritis affects multiple tissues within a joint, causing severe inflammation and tissue degeneration, but current treatment options are inadequate in part due to rapid clearance of drugs injected into the joint and lack of tissue-targeted delivery. This project will modify a promising OA drug by making it positively charged, utilizing its interaction with negatively charged cartilage to enhance cartilage penetration and retention, thereby transforming cartilage from a barrier to drug entry into a drug depot that can enable sustained delivery to cartilage and neighboring joint tissues. The strategy developed through this work can enable clinical translation of a variety of osteoarthritis drugs that are currently limited due to a lack of effective delivery techniques.